RISK AND PREDICTORS OF INTRACTABLE EPILEPSY IN CHILDREN

DESCRIPTION: (Adapted from the Applicant's Abstract). This application is to continue an ongoing community-based study of the risks and predictors of intractable epilepsy in a prospectively identified cohort of children with newly diagnosed epilepsy, recruited from offices of child neurologists in Connecticut. Information comes from medical record review, interviews and follow-up calls. The primary goals are to determine the probability and to identify predictors of intractable epilepsy and of remission. Epilepsy is a common disorder. Through the 1980's the estimated cumulative risk of childhood and adolescent epilepsy was about 1.0% with remission occurring to 70% to 80%. Despite overall high remission rates, a substantial minority, 10-20%, develop intractable epilepsy, a severe, chronic, disabling condition. There is almost no information about the risk or predictors of intractability children. This is especially important with the increasing use of epilepsy surgery in children which has occurred in the nearly complete absence of any information about prevention, prediction, and eventual remission (without surgery) of intractability. Very recent (1993-1994), population-based studies have reported 40-50% decreases in the incidence of childhood epilepsy, possibly secondary to changes in causes of epilepsy and also improvements in diagnosis with correct recognition of events that are often mistaken for, but which are not epilepsy. Consequently, what is diagnosed as epilepsy today may differ substantially from that in the past, and earlier studies may no longer be fully informative about epilepsy today. This study is unique because it has a primary focus on intractable epilepsy, and it will provide information about remission of childhood onset epilepsy at it is currently diagnosed and treated. Such information can be used to plan treatment strategies, identify high risk patients in whom aggressive approaches may be taken and who may be good candidates for clinical trials, to educate and counsel families, and to provide information to guide future research into causes, mechanisms, treatment, and ultimately even the prevention of some forms of epilepsy.